Data Management Core

The breadth and multidisciplinary nature of this project entails the generation, management, and analysis of
numerous distinct data types and workflows. To address this need, the Data Management Core (DMC) will
provide centralized data science support by establishing robust support infrastructure that will be essential to
facilitate effective collaboration throughout the project. The DMC includes an exceptionally experienced
leadership team, directed by Dr. Mark Schnitzer (Lead), with the assistance of Dr. Grégory Scherrer (Co-lead),
Dr. Anastasia Ivanova (Collaborator), Program Manager Josh Blair, and institutional support staff including the
UNC Research Data Management Core. Importantly, Dr. Schnitzer, Dr. Scherrer, and Program Manager Blair
will each actively contribute to both the DMC and Administrative Core (AC), thereby ensuring the intrinsic
collaboration of these two U19 support cores to effectively meet the needs of this research program. Together,
these DMC personnel will provide comprehensive data management support throughout the drug discovery
project by accomplishing the following Aims: centralize data management infrastructure, tools, and expertise
(Aim 1); manage data harmonization, aggregation, and analysis, and sharing (Aim 2); and identify and enforce
data management standards and best practices (Aim 3).